The NF-kappaB modulator PDLIM2 as an intrinsic checkpoint of alveolar macrophages critical for lung innate immunity, inflammation and diseases

Abstract
Pneumonia is a common cause of mortality, particularly in patients with lung cancer or lung diseases. Alveolar
macrophages (AMs), the primary phagocytes that serve as the major sentinels in the lung, have been believed
to be the main culprits of the fatal pathogenesis. However, it remains largely unknown how these key innate
immune cells are transformed to promote lung cancer or lung diseases and to increase vulnerability to infection.
In fact, it is still largely unknown how AMs are armed with the strong ability to clear pathogens and mutated cells
while simultaneously maintaining immune tolerance within the lung under normal conditions. To address those
scientifically and clinically important issues, we have recently identified a unique characteristic of AMs in the
inherent expression of the immune checkpoint PD-L1 and a previously unknown role of PD-L1, via cis-
interaction with CD80, in rendering AMs highly phagocytic. PD-L1 also arms AMs with a super T-cell
suppressive ability, indicating an innovative mechanism by which AMs provide optimal protective immunity and
tolerance within the lung. Furthermore, we have identified the PDZ-LIM domain-containing protein PDLIM2, a
tumor suppressor recently uncovered by us, as a new determinant of AMs required for CD80 induction
and AM phagocytosis. By promoting degradation of the master pro-inflammatory transcription factors NF-B
RelA and STAT3 in the nucleus, PDLIM2 is also required to restrict monocyte pulmonary recruitment and
differentiation into AMs and to inhibit AM inflammatory activation, thereby limiting inflammation. Amazingly,
selective deletion of PDLIM2 in AMs and myeloid cells alone is sufficient to induce lung cancer in mice
and makes animals more vulnerable to deaths by the bacterial endotoxin LPS. On the other hand, PDLIM2
is repressed in the AMs of patients with lung cancer, chronic obstructive pulmonary disease (COPD), and
interstitial lung diseases (ILDs), and this repression is associated with disease severity and poor patient survival.
Of note, PDLIM2 repression in AMs is induced both in vivo and ex vivo by smoking, the most predominant cause
of lung cancer and diseases and a prominent risk factor for pneumonia and pneumonia death. Based on these
original new discoveries, we hypothesize that PDLIM2 repression in AMs not only promotes lung cancer and
lung diseases but also increases vulnerability to lung infection. To test the hypothesis, we will determine the
physiological and pathophysiological significance and the detailed mechanisms of the novel PDLIM2/CD80/ PD-
L1 signaling pathway in AM phagocytosis, immune response, and bacterial pneumonia. These studies will
improve our understanding of lung innate immunity, inflammation, infection, and pathogenesis, and may reveal
new therapeutic targets and approaches for better lung disease treatment.

Public health relevance
Project Narrative Bacterial pneumonia is a particularly common and devastating health problem that affects people of all ages and health status, and is associated with high morbidity, mortality, and healthcare costs. The proposed studies will investigate the mechanisms by which lung macrophages provide optimal protective immunity to protect from bacteria within the lung and by which these key immune cells are deregulated for pneumonia and death. These studies will thus improve our understanding of lung innate immunity, physiology, and immunopathology, and may lead to novel therapeutic approaches to prevent and treat pneumonia and other lung diseases.